University of Pittsburgh/Magee-Womens Research Institute Women's Reproductive Health Research Across the Lifespan (Pitt-MWRI WRHR)

Background: The University of Pittsburgh Department of Obstetrics, Gynecology and
Reproductive Sciences (OBGYN) and Magee-Womens Research Institute (Pitt-MWRI) propose
to lead a career development program entitled Women’s Reproductive Health Research Across
the Lifespan (Pitt-MWRI WRHR). Pitt-MWRI is deeply committed to training the next generation
of physician-scientists in reproductive biology and women’s health. As one of the research
leaders in our field, we understand the significance of scientific discovery, and the need to
translate the results of research into knowledge and skills for clinicians, and ultimately, into
improvements in reproductive health, women’s health and the health of their offspring. Our
fundamental goals are to provide advanced training for talented Pitt OBGYN physician scholars
in impactful interdisciplinary research across the lifespan of women, and mentor them as they
develop a strong scholarly foundation for a productive and sustainable career in the field of
women’s reproductive health. Our program spans training in basic, translational, clinical, health
services, and community research and focuses on pathogenesis and personalized diagnostics,
therapeutics and prevention for women of all ages. Our goals are aligned with the Eunice
Shriver Kennedy NICHD strategic goals and objectives, cross-cutting topics and aspirational
goals. We strongly believe that reproductive health research is essential to propel progress in
care for women. Few OBGYN Departments have the critical mass of reproductive biology and
women’s health researchers, the mentoring environment and the infrastructure to distinctively
target training for OBGYN physician scientists. Pitt-MWRI excels in all these areas. We have an
outstanding track record of training, supporting and retaining previous WRHR scholars who are
broadly recognized as leaders in our field. Given the breadth of scientific skills among our
OBGYN primary mentors, established collaborations with outstanding mentors across the
University of Pittsburgh, our training program that emphasizes multidisciplinary mentoring,
classroom-based education, team science and grant writing, and our large pipeline of OBGYN
trainees, our Pitt-MWRI training program will enable each graduating scholar to embark on a
successful career as a physician-scientist poised to contribute to the improvement of women’s
health.

Public health relevance
PROJECT NARRATIVE Conditions specific to women, conditions that disproportionately impact women, and conditions that affect women differently are poorly understood and insufficiently studied. This proposal is directly relevant to the health of women and their children, as it supports outstanding training of OBGYN physician-scientists in women’s reproductive health research. The basic, translational and clinical science tools acquired through this training will enable tomorrow’s physician-scientists to make discoveries that will translate to improved health for women across the lifespan.